Administrative Core (A)

Project Summary/Abstract for Administrative Core
The objective of the Administrative Core (Core A-Morimoto) is to manage the interactions and progress of the
Projects and Cores of this proposal; to ensure they are in constant and convenient communication, and to
maximize the benefits of Project and Core collaborations to enhance the scientific output and impact. Due to
the highly interdisciplinary nature of our approach and the distance separating the teams, we have placed a
priority on communication (virtual and in person exchanges) to ensure that there are productive interactions
among all team members. To help achieve these goals, we propose three Specific Aims for the Administrative
Core: 1) To maximize communications among the Project and Core Leaders; 2) To organize the annual
external review; 3) To strengthen collaborations and maximize interactions among Projects and Cores.